Proteogenomic Characterization of Tumor Tissues and Preclinical Models with High Precision

Summary
During the last 12 years of since CPTAC2, the JHU Proteome Characterization Center (JHU/PCC)
has repeatedly demonstrated superior technological innovation and robust data generation that
have played critical roles in the success of CPTAC's core mission of accelerating the understanding
of the molecular basis of cancer through the application of large-scale proteome analysis
technologies to different cancer types. For this project, we aim to generate accurate, reproducible,
sensitive, quantitative, and multiplexed proteomic analysis using optimized and standardized high-
throughput technologies. We will leverage our established Center infrastructure and capitalize on
our success in clinical cancer proteogenomic discoveries to characterize proteins and protein
phosphorylation from The Children's Hospital of Philadelphia, on behalf of itself and the Children
Brain Tumor Tissue Consortium (CBTTC), the Children's Brain Tumor Network, a part of the Center
for Data Driven Discovery in Biomedicine at CHOP ) (CBTN). We will identify unique features that
are inherent to proteins such as phosphorylation that have been included in our current PCC.
Understanding the molecular network in carcinogenesis is essential for the advancement of
precision cancer medicine and development of a successful strategy to reduce cancer mortality.

Public health relevance
Project Narrative This application aims to characterize biological and clinical specimens to determine the quantitative changes in protein abundance and protein phosphorylation to discover, verify, and confirm cancer protein targets associated with genomic alterations using state-of-the-art mass spectrometry based proteomics technologies.